Brain Health Equity Research Collaborative

Project Summary
Racial and ethnic disparities in neurologic disease mortality and outcomes contribute to
thousands of avertible deaths per year. The burden of neurologic diseases disproportionately
impacts Black and Hispanic communities; however, Black, and Hispanic patients are
underrepresented in clinical trials for neurologic conditions. Community-engaged research holds
promise for improving our understanding of factors contributing to neurologic disease disparities;
however, most institutions lack structural elements needed for meaningful community
engagement. The goal of this project is to build infrastructure for community-engaged research
interventions for three neurologic conditions affecting brain health. We hypothesize that stroke,
vascular cognitive impairment and dementia, and Parkinson’s disease share similar social and
clinical characteristics that underly racial and ethnic disparities in their outcomes. We have
developed a conceptual model with multiple testable hypotheses that can facilitate intervention
development and increase our understanding of mechanisms contributing to neurologic disease
disparities. Through the proposed Brain Health Equity Collaborative, we will build the structural
capacity needed to design equitable community-engaged interventions. First, in collaboration
with community-based organizations, we will establish community-level and patient-level
oversight with a Brain Health Equity Oversight Committee and a Community Advisory Board.
Next, we will used mixed methods research to identify multilevel barriers to research inclusion for
Black and Hispanic patients with stroke, vascular cognitive impairment and dementia, and
Parkinson’s disease. Lastly, we will design and pilot a Brain Equity Curriculum that incorporates
knowledge gained and serves as a platform for bidirectional community and academic learning
and knowledge exchange. Upon completion of the project, we will have gained the partnerships,
knowledge, and infrastructure necessary to design rigorous clinical trials with equitable
representation from communities that shoulder the burden of neurologic disease.

Public health relevance
Project Narrative Neurologic conditions including stroke, vascular cognitive impairment and dementia, and Parkinson’s disease contribute to the leading causes of death and disability in the United States and globally. Stark racial and ethnic disparities in the burden of these diseases exist, and there is an urgent need to develop community-driven interventions that promote equity in neurologic disease outcomes. Our multidisciplinary team aims to collaborate with community-based organizations to establish a Brain Health Equity Collaborative which will facilitate equitable academic and community partnerships for clinical trial development.